Research Training in Childhood Cancer

PROJECT SUMMARY
This Ruth L. Kirschstein National Research Service Award Postdoctoral Research Training Grant renewal
application is submitted in response to Program Announcement PA-16-152. This is a renewal application to
continue to provide institutional T32 awards to train young physician-scientists who will become independent
investigators conducting research addressing important problems in human health. The application requests
continued resources to support four physician/scientists each year with MD or MD/PhD degrees who receive
mentored research that focuses on the etiology, pathogenesis, and treatment of pediatric malignancies. The
overall objective of this T32 program is to train new investigators who will improve the care of children with
cancer. The rationale for the program is based on the substantial burden of pediatric cancer in the United
States and the well-documented and critical need to provide mentored career development support for young
physicians that will enable them to become fully independent and productive laboratory researchers. As such,
they will be poised to improve the health of children with cancer throughout the world by bringing state-of-the-
art expertise to bear on problems such as inherited predispositions, environmental factors, the toxic and
relatively non-specific nature of current therapies, and long-term adverse effects of mutagenic treatments. The
design of this program involves harnessing the expertise of world-class research scientists who serve as
mentors for interdisciplinary training. We have successfully implemented distinct training tracks for laboratory-
based and clinical/translational investigators. We believe that the progress of this T32 program since its
inception in 2007 demonstrates that UCSF has the vision, experience, and infrastructure to train the next
generation of leaders in childhood cancer research. In this renewal application, we provide evidence that the
Department or Pediatrics and Division of Oncology together with the broader UCSF research community
comprise an exceptional environment for preparing young physicians for productive careers as independent
investigators the field of childhood cancer. This application describes a comprehensive plan for identifying,
training, and mentoring these individuals. This application is directly relevant to human health as it requests
funds to support mentored career development for outstanding young physician/investigators who will become
independent researchers in the field of childhood cancer. Programs like this one represent an investment in the
future of public health as the researchers who are trained through this award will be equipped to harness state-
of-the-art research techniques to attack a formidable health problem in the pediatric population. The long-term
outcome of intensive and innovative training provided by this T32 award will be effective new treatments for
childhood cancers.

Public health relevance
Project Narrative This competitive renewal application of a Ruth L. Kirschstein National Research Service Award Postdoctoral Research Training Grant that has the overall goal of training physicians (MD or MD/PhD) for independent research careers investigating the etiology, pathogenesis, and treatment of pediatric cancer. We believe that the outstanding research faculty, institutional resources, educational programs, and pool of highly qualified trainees at UCSF result in an outstanding environment for achieving this goal.